ASCERTAINMENT OF HYPERTENSIVE PATIENTS FOR GENETIC STUDIES

Recruit black and white hypertensive subjects including hypertensive siblings and unrelated normotensive black and white control subjects for acquisition of DNA. Test that certain variant genes increase susceptibility to hypertension.